LIMB LOSS PRESERVATION REGISTRY - TASK ORDER 3 - SUSTAINABILITY PLANNING

Clinical registries are repositories of clinical information that can improve the standard of care and inform research in a particular field. As a leading funder of amputation, prosthetic development, and post- amputation rehabilitation research, NCMRR, in partnership with DoD, seeks to establish a Limb Loss and Preservation Registry of clinical information on civilians, military personnel, and veterans who experience limb loss or preservation at care sites outside the DoD, or Department of Veterans Affairs. This registry shall include information on limb preservation care, pre-operative care, operative care, acute and sub-acute management, device fitting and use, and rehabilitation care as provided by private, not-for-profit, or academic medical centers.